Functional genetic basis of Wolbachia-Drosophila endosymbiosis

Project Summary/Abstract
The Russell Lab seeks to understand how bacterial symbionts of eukaryotic hosts are transmitted from one
host generation to the next, and how these strategies evolve over time. Our research focuses on the
intracellular inherited alphaproteobacterial Wolbachia symbionts of Drosophila melanogaster and congeners.
These bacteria are capable of inducing a wide range of phenotypes in their hosts, from reproductive
manipulations such as cytoplasmic incompatibility that bias offspring production towards infected females, to
viral suppression that reduces titer and transmission from vector species to human populations. These
phenotypes are currently employed to control host populations. However, little is known about the cellular,
molecular, and evolutionary mechanisms underpinning these phenotypes or the transmission mechanisms that
link Wolbachia between host generations. Over the next five years, we aim to reveal the microevolutionary
processes driving host and symbiont evolution, the developmental processes that enable symbionts to induce
their own host cell types, and the molecular mechanisms that link host and symbiont phenotypes using our in
vivo and in vitro Wolbachia-infected Drosophila model system. To capture the rare and ephemeral horizontal
transmission events that have occurred across Wolbachia’s evolutionary history, we will study diverse mixed
strain infections in Drosophila cell lines and track their genome evolution. We will study the genomic basis of
symbiont domestication after a host-switching event by leveraging historical stocks collected immediately after
a Wolbachia strain entered and swept to fixation. We will study the downstream impacts of coevolutionary
interactions by interrogating host and symbiont gene expression to identify novel symbiont-induced host
developmental programs and molecular mechanisms. High-throughput genomic assays such as these have
revealed promising candidate genes underlying Wolbachia’s ability to transmit to host offspring through the
germline and infect uninfected cells efficiently. Using our in vivo and in vitro system, we will study the functional
implications of these factors on the localization patterns of Wolbachia within and among host cells, Wolbachia’s
ability to establish stable infections, and the fertility reinforcement phenotypes demonstrated by some strains.
The overall vision for our research program is to develop a robust understanding of Wolbachia functional and
evolutionary genetics in Drosophila to enable informed biological control applications. It is vital that we know
the evolutionary genomic outcomes of divergent strains infecting novel hosts, as this is a possible outcome of
releasing Wolbachia-infected mosquitoes into natural ecosystems. Our studies on the novel genetic regulatory
and functional implications of host-symbiont molecular coevolution will reveal new biological pathways and
mechanisms that could be leveraged for biomedical applications. Lastly, our approaches for functional genetic
testing of candidate genes in Wolbachia-infected Drosophila cells and flies will enable us to validate
host-symbiont interaction hypotheses and ascribe direct functions to Wolbachia genes.

Public health relevance
Project Narrative Microbial symbiosis is ubiquitous among eukaryotes, has enabled many remarkable lifestyles and strategies, and is now being exploited to control vector host populations for reduced disease transmission. The intracellular Wolbachia bacterial symbiont of insect and filarial nematode species induces diverse host phenotypes and is highly tractable in the lab. Here, we propose to use this powerful system to reveal how symbiont and host genomes evolve over short timescales, how symbiotic partners co-evolve to innovate on canonical molecular functions, and how we can use our in vitro Wolbachia culture system to directly assay gene function in unculturable microbes.